Optimized development of novel leaflet biomaterials for replacement heart valves

Project Summary
The ideal replacement heart valve (RHV) should have sufficient durability, resistance to
thrombosis, and excellent hemodynamics that lasts the remaining patient lifetime, which does
not yet exist. The majority of current RHV are ‘bioprosthetic’ heart valves (BHV), with leaflets
fabricated from chemically treated pericardium, as originally developed in 1971. While providing
for an initially effective therapy, all BHV continue to suffer from limited durability resultant from
mineralization and mechanical fatigue. The growing use of minimally invasive transcutaneous
designs that utilize thinner leaflets results in even greater leaflet mechanical demands and may
suffer from more limited durability. In addition, all pericardial biomaterials have intrinsic
structural variability that greatly limits their ability to be further improved for extended
durability. This present lack of improved RHV biomaterials continues to limit our ability to
adequately address RHV limited durability. We have developed a class of hydrogel-coated
electrospun (HES) biomaterials for cardiovascular applications. HES biomaterials have been
successfully utilized as vascular grafts, in which a luminal hydrogel provided thromboresistance
and an electrospun mesh sleeve provided mechanical reinforcement. HES biomaterials can be
fabricated over a wide range of mechanical behaviors that encompass RHV design requirements,
which we have shown can be accurately modeled. When combined with our high speed RHV
simulation methods, it is possible to identify optimal biomaterial and leaflet geometry
characteristics, so that we can develop RHV with greater durability. To facilitate both HES
biomaterial development and leaflet functional performance, we will extend a novel non-
contacting optical method to sensitively detect fiber structures with pixel-level resolution and
exploit our significant in vitro and large animal model evaluations. We thus hypothesize that the
rational development of HES biomaterial-based RHVs will lead to a new generation of durable
replacement heart valves.

Public health relevance
Project Narrative The ideal replacement heart valve (RHV) does not yet exist. The growing use of minimally invasive transcutaneous designs that utilize thinner leaflets results in even greater leaflet mechanical demands and may suffer from more limited durability. We will conduct rational development of a novel heart valve leaflet biomaterial that will lead to a new generation of durable replacement heart valves.